SPERM MORPHOLOGY AND VAGINAL CYTOLOGY EVALUATION

This project has two primary objectives: 1) to collect data from rodent male and female reproductive systems at the end of 90 day studies, to determine if there are adverse effects of treatment on these systems. These data are used to identify candidates for further reproductive toxicity testing. 2) to collect videographic data on sperm motility from animals treated under the Reproductive Assessment by Continuous Breeding contract. The purpose of this is to identify meaningful relationships between changes in sperm motility patterns, and fertility. We don't know these relationships now, despite widespread use of these machines. This will help the field focus in on the endpoints with the greatest relationship to fertility, to allow us to spend our decreasing resources more efficiently in the future.